The FIRSTT Trial: Assessing Outcomes of Minimally Invasive Leiomyoma Therapies

DESCRIPTION (provided by applicant): Uterine leiomyomas (fibroids or myomas) are diagnosed in one-fourth of all women and up to 75 % of black women. The direct health care costs attributable to leiomyomas exceed $2.1 billion annually. However, our work and that of others, report that indirect costs (disability and absenteeism) are a large part of total costs for women with uterine fibroids. Addressing the symptoms of clinically significant uterine fibroids and controlling health care costs from a societal perspective are both important goals. Despite the prevalence and morbidity of this disease and the significant costs of treatment, there is a dearth of evidence to guide therapy. Two minimally-invasive FDA-approved techniques treat leiomyomas in a wide variety of sizes and locations: uterine artery embolization (UAE) and MRI-guided focused ultrasound surgery (MRgFUS). However, they differ significantly in approach, mechanism of action and side effects and they have never been directly compared. We therefore propose the FIRSTT trial: Fibroid Interventions: Reducing Symptoms Today and Tomorrow), a randomized clinical trial treating 220 women with symptomatic uterine leiomyomas with UAE or MRgFUS and following them for three years. A racially diverse cohort of subjects will be achieved by recruiting through Mayo Clinic Rochester and Duke University. This trial is powered to compare short- and long-term outcomes, adverse events, predictors of outcome, and costs of each treatment. The specific aims of this project are: 1) To report comprehensive outcomes and predictors of outcome following UAE and MRgFUS. 2) To quantitate and compare the ovarian impairment following UAE and MRgFUS. 3) To produce an economic analysis of UAE and MRgFUS treatment from a U.S. societal perspective.

Public health relevance
PUBLIC HEALTH RELEVANCE: Uterine leiomyomas or fibroids are found in one-fourth of all women and up to three-fourths of black women. Fibroids are the leading cause of hysterectomy and account for health care costs over $2.1 billion annually. This study proposes to study the outcomes and limitations of two widely used alternatives to hysterectomy for fibroids: uterine artery embolization (UAE) and magnetic resonance imaging guided focused ultrasound surgery (MRgFUS). Relevance Uterine leiomyomas or fibroids are found in one-fourth of all women and up to three-fourths of black women. Fibroids are the leading cause of hysterectomy and account for health care costs over $2.1 billion annually. This study proposes to study the outcomes and limitations of two widely used alternatives to hysterectomy for fibroids: uterine artery embolization (UAE) and magnetic resonance imaging guided focused ultrasound surgery (MRgFUS). __SpecificAimsTextDelimiter__ A. Specific Aims Uterine leiomyomas (fibroids or myomas) are diagnosed in one-fourth of all women and up to 75 % of black women. The direct health care costs attributable to leiomyomas exceed $2.1 billion annually. However, our work and that of others, report that indirect costs (disability and absenteeism) are a large part of total costs for women with uterine fibroids. Addressing the symptoms of clinically significant uterine fibroids and controlling health care costs from a societal perspective are both important goals. Despite the prevalence and morbidity of this disease and the significant costs of treatment, there is a dearth of evidence to guide therapy. Two minimally-invasive FDA-approved techniques treat leiomyomas in a wide variety of sizes and locations: uterine artery embolization (UAE) and MRI-guided focused ultrasound surgery (MRgFUS). However, they differ significantly in approach, mechanism of action and side effects and they have never been directly compared. UAE employs angiographic occlusion of the uterine arteries as a global uterine treatment inducing ischemic necrosis. This global approach leads to an adverse impact on ovarian function and normal myometrium and thus has significant implications for women desiring pregnancy. In contrast, MRgFUS targets the interstitium of individual fibroids and produces thermoablative coagulative necrosis. This myoma-specific approach is more selective but less comprehensive and appears to lead to less symptomatic improvement and higher rates of additional interventions. We therefore propose the FIRSTT trial: Fibroid Interventions: Reducing Symptoms Today and Tomorrow), a randomized clinical trial treating 220 women with symptomatic uterine leiomyomas with UAE or MRgFUS and following them for three years. A racially diverse cohort of subjects will be achieved by recruiting through Mayo Clinic Rochester and Duke University. This trial is powered to compare short- and long-term outcomes, adverse events, predictors of outcome, and costs of each treatment. The ultimate objective is to ascertain the best course of treatment for each woman with the goal of improving outcomes and developing standard protocols. The specific aims of this project are: 1.) To report comprehensive outcomes and predictors of outcome following UAE and MRgFUS The primary outcome will be efficacy: specifically the need for additional medical or surgical intervention following initial treatment. However multiple other long term outcomes including disease specific quality of life (UFS-QOL), control of menstrual bleeding (AMCOQ), and uterine and myoma volume reduction will be assessed. Short-term outcomes (pain scores, return to work and general health status [SF-36]) and safety outcomes (adverse events) will also be tracked. 2.) To quantitate and compare the ovarian impairment following UAE and MRgFUS We will establish the proportion of women having disruption of menstrual cyclicity and those becoming menopausal following therapy and examine subclinical impaired ovarian reserve by collecting serum at baseline and 12-, 24-, and 36-months following treatment for assay of antimüllerian hormone (AMH) and follicle stimulating hormone (FSH). 3.) To produce an economic analysis of UAE and MRgFUS treatment from a U.S. societal perspective. We will determine a disease-specific resource utilization including direct and indirect costs including over-the counter remedies and alternative and complementary therapies. In addition we will perform a cost effectiveness analysis assessing the incremental mean costs per quality-adjusted life with each therapy. 1